ANTICONVULSANT MECHANISMS OF ACTION

Murine spinal cord and cortical neurons in primary dissociated cell culture and rat hippocampal pyramidal neurons in brain slice will be used to investigate the mechanisms of action of the anticonvulsant drugs phenytoin (Dilantin) and carbamazepine (Tegretol). Intracellular recording techniques will be used. We will examine the hypotheses that: 1) phenytoin and carbamazepine have anticonvulsant action by limiting sustained, high frequency repetitive firing and 2) that anticonvulsant limitatio fo repetitive firing is due to use (frequency) dependent sodium channel block. We will investigate carbamazepine actions on spinal cord neurons in cell culture. We will determine if carbamazepine alters: 1) spontaneous activity and convulsant-induced paroxysmal bursting, 2) resting membrane potential or conductance, 3) calcium-dependent action potentials and 4) postsynaptic amino acid responses. We will determine if phenytoin and carbamazepine limit sustained repetitive firing of cortical neurons in cell culture and hippocampal pyramidal neurons in brain slice. We will determine the mechanism of phenytoin- and carbamazepine-induced limitation of sustained repetitive firing in spinal cord neurons in cell culture.